Adaptation and Implementation of Safety Planning for Suicide Prevention Among Youth in Botswana

PROJECT SUMMARY
Reducing the high burden of death by suicide in low- and middle-income countries requires the effective
implementation of evidence-based practices for suicide prevention. In Botswana, suicide disproportionately
affects youth. Specifically, high school and university-age students experience elevated rates of suicide-related
thoughts and behaviors. The Safety Planning Intervention (SPI) is an established practice for suicide prevention.
To maximize successful implementation of SPI among youth in Botswana, there is a need to adapt SPI for use
in the target setting and to use participatory methods to co-design implementation strategies. Schools offer an
ideal setting to implement SPI to increase reach to individuals in greatest need. This research will focus on youth
aged 15-24 years in the public educational sector. Through a partnership with the University of Botswana and
local public schools, we will employ rigorous participatory methods to culturally adapt SPI and inform
implementation of SPI. Specifically, over the three-year period, we will adapt SPI through linguistic and content
modifications, task-shift delivery of SPI to guidance and counselling (G&C) teachers, co-create strategies to
implement the adapted SPI into schools, and pilot implementation strategies. First, we will apply the World Health
Organization guidelines to employ a three-step process of forward translation, back translation, and focus group
discussions to complete linguistic and content adaptations. Second, we will develop implementation strategies
for SPI. We will elicit perspectives on determinants of implementation (e.g., barriers and facilitators) of SPI
through semi-structured interviews with a multi-partner group of implementers (e.g., teachers) and leadership
(e.g., Ministry of Education and Skills Development (MoESD) officials). A group of experts (e.g., implementation
scientists, Ministry of Health and Wellness leadership, MoESD leadership, G&C teachers, mental health
clinicians, youth, and educational leadership) will operationalize the input gleaned from the interviews through
the systematic process of implementation mapping that integrates theory, participatory input, and context. This
work will yield a menu of contextually and partner-informed implementation strategies for the adapted SPI among
youth in schools in Botswana. Third, we will conduct a pilot hybrid type III effectiveness-implementation trial to
test the implementation strategies among six public schools in the South East region of Botswana, during which
we will measure the impact on feasibility, acceptability, appropriateness, fidelity, and preliminary effectiveness
(suicidal ideation and behavior). This work will yield generalizable insights for other regions and community
engagement engendered through the research process. Leveraging the new partnerships formed for this
proposal, future efforts can systematically evaluate the impact of the strategies on reducing death by suicide and
increasing the uptake of SPI across Botswana.

Public health relevance
As recognized by priorities of NIMH, suicide among youth is a leading cause of death globally affecting both high-income countries (e.g., United States) and low- and middle-income countries (e.g., Botswana). Innovative strategies to implement evidence-based interventions among youth in Botswana will generate generalizable insights for successful uptake of suicide prevention, particularly in areas in the United States that face similar barriers to Botswana. Examining translational approaches across contexts will contribute to the development of scalable solutions that benefit youth around the world.